Project 1

Most luminal B breast cancers (LBBC; ER+, HER2-wt, Ki67>14%) carry a good prognosis. However, approximately 20% of LBBC are highly aggressive and resistant to current therapies. There have been many failed attempts to therapeutically target MYC. These attempts have failed, in part, due to our current inability to separate the cancer-promoting activities of MYC, mechanistically or therapeutically, from its normal essential cellular functions. In preliminary data, we show that the cancer-transforming ability of MYC is dependent on three lysine (K) residues of MYC (K149, K158, and K323) that are major substrates for acetylation by the histone acetyltransferases (HATs) p300 and GCN5. Guided by our preliminary data, here we aim to dissect the cofactors and molecular mechanisms by which these MYC acetyl-K (AcK) residues promote cell transformation and initiation and progression of LBBC. Our long-term goal is to identify new “druggable” targets to improve survival of patients most affected by aggressive LBBC. Guided by our preliminary data, we hypothesize that a gene-selective MYC-AcK signaling pathway drives the aggressive tumor cell biology of therapy-resistant LBBC and involves transcription cofactors and epigenetic coregulators that “write” and/or “read” AcK marks on MYC and histones, perhaps including cofactors co-overexpressed with MYC in LBBC, such as PIN1, GCN5, p300, and/or YEATS2. Aim 1 will define the impact of MYC-AcK dependent signaling in mammary epithelial cell transformation and in the aggressive biology of LBBC. Aim 2 will characterize the molecular mechanisms of MYC-AcK dependent gene regulation directly in LBBC from patients.

Public health relevance
In luminal B breast cancer (LBBC), MYC activation predicts therapy resistance and poor prognosis. Our preliminary data show that substitution of MYC-AcK residues with arginine (R), which cannot be acylated (i.e., R149, R158, or R323), blocks MYC-driven malignant transformation of immortal human MCF10A mammary epithelial cells. Notably, the R149 mutation also blocks the ability of MYC to immortalize normal primary human mammary epithelial cells (HMECs). High MYC in LBBC biopsy specimens correlates with overexpression of GCN5 and other MYC cofactors, including PIN1 and YEATS2. PIN1 is a peptidylprolyl isomerase that binds and isomerizes the transactivation domain of MYC and enhances recruitment of GCN5 and p300 HATs. Hence, PIN1 may facilitate acetylation of MYC on target genes. PIN1 is overexpressed in many cancers and cooperates with MYC in transformation of MCF10A cells. However, the roles of MYC-AcK signaling and of PIN1 in normal mammary cell transformation and in LBBC are unknown. YEATS2 was identified by our lab as a GCN5-associated subunit of the human ATAC complex. Our published/preliminary data show that YEATS2 interacts with MYC and activates MYC target genes and cell proliferation. Guided by our preliminary data, we hypothesize that a gene-selective MYC-AcK signaling pathway drives the aggressive tumor cell biology of therapy-resistant LBBC and involves transcription cofactors and epigenetic coregulators that “write” and/or “read” AcK marks on MYC and histones. Aim 1: Define the impact of MYC-AcK dependent signaling in mammary epithelial cell transformation and in the aggressive biology of LBBC. (Martinez & Jones) 1.1 Define the roles of MYC-AcK sites and test cooperation with associated cofactors in mammary cell immortalization, malignant transformation, and progression. 1.2 Identify MYC-AcK regulated genetic programs in transformed HMECs and LBBC cells. 1.3 In LBBC, does MYC-AcK signaling predict recurrence? Aim 2: Characterize the molecular mechanisms of MYC-AcK dependent gene regulation in transformed mammary epithelial cells and in LBBC from patients. 2.1 Identify the mechanisms of MYC-AcK dependent transcription. 2.2 Test MYC-AcK molecular interactions in LBBC from patient samples. Impact: Our goal is to improve treatment of highly aggressive LBBC.